Research Training Program in Disease Oriented Neuroscience (R25)

SUMMARY
This Research Training Program in Disease Oriented Neuroscience is designed to facilitate the transition
between graduate training and a research-based career in neurology. R25 program trainees receive career
mentoring from experienced clinician scientists in Neurology along with research mentoring from leading
clinical neuroscience laboratory research faculty drawn from multiple departments and schools within the
University of Pennsylvania. A focused educational program supplement laboratory research and includes
training in translational research methods, applications, and the responsible conduct of research. The program
is conducted in a large research-oriented institution with leading residency programs in adult and child
neurology that trains some of the best candidates in the country and has an outstanding track record of
fostering research oriented careers and trainee diversity. Over the past program period, the R25 pathway has
been fully integrated into the residency training program and impacts all phases including residency application
review, applicant visit and interviews procedures, advance mentorship and research opportunities for
matriculated applicants, intensive support for the selection of mentors and the development of an R25
supplement request, and multiple levels of clinician scientist career development support. Between adult and
child neurology, there are over 150 faculty members in our department, ranging from master clinicians, clinical
educators, and clinical investigators to physician/scientists and basic scientists. Over 80% of graduating
residents over the past 15 years have remained in academic medicine, and many have chosen careers as
clinician scientists. The Hospital of the University of Pennsylvania and Children's Hospital of Philadelphia at the
Perelman School of Medicine, where most of the clinical residency and fellowship training occurs, are located
within a highly compact university campus in West Philadelphia spanning a radius of less than one half mile.
Penn is also home to the first neuroscience institute in the country, the Mahoney Institute for Neurosciences,
which consolidates almost 200 faculty members from 32 departments and six schools engaged in
neuroscience research at Penn. The range of research opportunities for our R25 trainees can thus be
extended to the wider neuroscience community inside and outside the Department of Neurology through co-
mentorship of trainees with a diverse array of eminent scientists carrying out research relevant to the NINDS
mission to reduce the burden of neurological disease.

Public health relevance
NARRATIVE The field of neurology is poised to make rapid advances in the treatment of neurological disorders, but the success of this endeavor depends on the availability of a cadre of academically based clinician scientists who are engaged in translational research, and who will catalyze the translation of advances between the laboratory and the bedside. The proposed program has been refined over two project periods and provides a facilitated and intensively mentored pathway to a research career as a clinician scientist in neurology.